Circadian rhythms and cell survival in lithium responsive bipolar disorder.

Bipolar disorder (BD) is a common mental illness that affects 1–2% of the world's population, including >100,000 veterans, causing severe mood symptoms, volumetric of loss of brain gray matter, and elevated rates of suicide. Among its symptoms, BD is associated with disrupted daily 24 hr rhythms (circadian rhythms) in sleep and activity. However, due to similarities and overlap with other psychiatric syndromes, it is commonly misdiagnosed and treatment delays are frequent. Lithium is an excellent treatment for BD, but 30–50% of lithium treated patients fail to respond fully to treatment and/or suffer side?effects. These factors cause needless delays from unsuccessful treatment, increasing cost, disability, and extending the window or risk for suicide. Because of these challenges, new techniques to diagnose BD, and more rapidly identify lithium responders would be of tremendous clinical utility. While the suprachiasmatic nucleus of the hypothalamus is the “master clock” for circadian rhythms, the genes that control circadian rhythms (“clock genes”) are functional in peripheral tissues and can be studied in cultured skin cells (fibroblasts) from patients. Lithium has effects on circadian rhythms in fibroblasts, altering the expression of clock genes, increasing rhythm amplitude (intensity) and lengthening period (the duration between cycles). Using bioluminescent reporter genes (Per2::luc), one can accurately study the circadian clock in tissues from BD patients and controls. Using this approach, we have identified clock gene abnormalities in BD, and circadian rhythm differences in period that distinguish lithium responsive and non? responsive BD patients. In other studies, we have identified neurotrophins as pharmacogenetic indicators of therapeutic response to lithium in BD patients. Interestingly, neurotrophins are expressed rhythmically under the control of the circadian clock. In this proposal, we aim to extend upon this work and synthesize these observations to 1) Establish a cellular model of lithium responsive BD based on cell death and protection by lithium 2) Determine the effect of circadian rhythm amplitude on regulating the vulnerability of neurons to oxidative/excitotoxic cell death and 3) Determine the relationship between circadian period and lithium responsiveness, focusing on neuroprotection by lithium. The methodological approach is molecular and cell based, using genetic (siRNA knockdown) and pharmacological means to manipulate circadian amplitude, period and overall rhythmicity in human fibroblasts, stem? cell derived induced neurons, and immortalized mouse hippocampal neurons. Following these manipulations, differences in circadian rhythm parameters (amplitude/period) and cell death will be measured in the absence and presence of lithium. It is expected that cells from lithium?responsive patients will be more able to benefit from the protective effects of lithium in cell death assays. Furthermore, short?period and high amplitude rhythms in cells will lead to greater resilience under conditions of excitotoxic/oxidative stress. Analysis will be conducted using curve fitting methods to measure rhythms and univariate statistical analyses to identify mean differences in cell survival based on phenotypic or circadian parameters. When complete, these studies may provide mechanistic insights into the vulnerability factors underlying BD, and molecular mechanisms underpinning lithium's mode of action in treating BD. By understanding these aspects of BD, it may be possible in the future to develop predictors of treatment response, diagnostic tools, or new treatment interventions based on these results.

Public health relevance
Bipolar disorder (BD) is a common mental illness that affects 1-2% of the world's population and ~100,000 veterans, causes mood symptoms, social/occupational disability and elevated rates of suicide. BD is associated with loss of brain volume and disruptions in daily (circadian) rhythms in sleep and behavior. Lithium is an inexpensive, effective treatment for BD that protects neurons, and restores circadian rhythms. However, 30-50% of patients with BD fail respond to lithium treatment and intolerable side effects are common. Lithium non-responsive patients are delayed in receiving effective treatment and require more expensive drugs. In order to gain insights that will allow for the future development of tools to identify lithium responsive patients rapidly, this study investigates the molecular interactions among circadian rhythms, neuroprotection and lithium in cell-based models of lithium response.